Chronic Pain and Risk of Alzheimer's-Related Neurodegeneration

7. PROJECT SUMMARY
The long-term goal of the proposed career development award is to provide the training necessary to develop
an independent research program investigating how chronic pain is related to dementia risk. Such research is
timely given recent links between chronic pain and a doubled risk of dementia due to Alzheimer's disease
(AD). Chronic pain may lead to general, AD-unspecific, neurodegeneration that increases susceptibility to AD
dementia, supported by studies linking chronic pain to smaller brain volumes in adults. Alternatively, recent
animal studies suggest that the biological processes underneath chronic pain may promote amyloidosis and
tau seeding, but there is less focus on the relationship of chronic pain and AD-related neurodegeneration in
humans. A training emphasis focused on incorporating biological measures will complement my existing
expertise in chronic pain, cognitive aging, and advanced statistical analysis to conduct this research program.
The proposed training goals are to: 1) attain proficiency in neuroanatomy and neuroimaging relevant to aging
and AD; 2) obtain competence in assessment and biology of pain; and 3) establish a multidisciplinary program
studying brain changes and AD risk. Training will involve a combination of formal coursework, and hands-on
activities, and discussion with mentors and other field experts. The Department of Psychiatry at the University
of California San Diego is an ideal environment for the proposed training activities with access to world-renown
researchers and research centers focused on chronic pain, neuroimaging, and Alzheimer's disease as well as
an excellent departmental record of career development for junior researchers. The proposed project will
examine how chronic pain relates to indicators of general neurodegeneration and AD-related
neurodegeneration across independent samples of older adults including the Framingham Heart Study, the
Religious Orders Study/Memory Aging Project, and the Vietnam Era Twin Study of Aging. Aim 1 will examine
how chronic pain relates to indicators of general neurodegeneration, including brain age, an estimation of age
based on thickness/volume across a wide arrange of AD-unspecific brain regions, as well as neurofilament
light, a protein released during neurodegeneration. Aim 2 will examine how chronic is associated with
indicators of AD-related neurodegeneration. Indicators include AD brain signatures capturing thickness/volume
and mean diffusivity in AD-vulnerable brain regions, biomarkers of amyloid and tau, and diagnosis of mild
cognitive impairment and AD dementia. Analyses will help clarify how chronic pain contributes to dementia risk,
either through general neurodegeneration or AD-related neurodegeneration. Multiple datasets will improve the
rigor of analyses by allowing for replication.

Public health relevance
PROJECT NARRATIVE Cases of Alzheimer’s dementia (AD) will triple by 2050, making preventative intervention on health- focused risk factors a major goal. Of recent interest is chronic pain, recently linked to a doubled risk of AD. This study will provide clarification by examining associations of chronic pain with indicators of general neurodegeneration and AD-related neurodegeneration.